WORK READINESS NEUROMETER

DESCRIPTION: (Adapted from the Investigator's Abstract). This application proposes to develop an inexpensive device, the work readiness neurometer, to quickly determine the degree to which an individual's basic neurocognitive functions have changed from her/his initial personal baseline level. This device will measure neurocognitive variables while the individual performs a brief battery of tasks in order to detect subtle changes in these variables over time. The device will be a convenient tool for detecting the existence of fatigue, or drug or alcohol intoxication before an impaired mental state can lead to impaired job performance and tragic accidents.